Informatics, Tissue Resource, and Pathology Core

Effective procurement and utilization of well-characterized tissue is essential to perform meaningful translational research. The Informatics, Tissue Resource, and Pathology Core (Core B) will work with each of the SPORE projects and with the Administrative and Biostatistics Cores to ensure maximum efficiency in the use of tissue for translational research directed at improving the prevention, detection, and therapy of melanoma. Core B will continue to provide investigators at The University bf Texas M. D. Anderson Cancer Center and other collaborating institutions with well-characterized, high-quality tissue, peripheral blood lymphocytes, plasma, arid serum samples from patients with melanoma treated at M. D. Anderson Cancer Center whose clinical, pathologic treatment, follow-up, and recurrence data are maintained iri a comprehensive relational database. Standardized procedures for procurement, processing, storage, quality control, histopathologic evaluation and distribution of samples will ensure optimal utilization and distribution of limited tissue samples according to the guidelines established by the Tissue Acquisition and Distribution Committee. A fully customized relational Core database tracks all samples from patient consent, to tissue acquisition and distribution of tissue and blood components to SPORE Projects. This system contains comprehensive clinical information on all patients as vyell as relevant histopathologic characteristics for all samples and provides information on sample availability for future distribution through an NCI-sponsored tissue network. As over 1200 new patients with melanoma are seen and treated at M. D. Anderson Cancer Center per year, this Core will be one of the largest available resources for translational research. The close relationship with the Biostatistics Core will allow an efficient analysis of the data produced by the different SPORE projects. Leadership foi' the Core is shared by a clinical investigator with expertise in melanoma patient care, database design and utilization and analysis of melanbma prognostic factors, and by a dermatopathologist with expertise in melanoma, including histopathologic evaluation, molecular analysis and quality-control procedures; both Co-leaders have expertise in melanoma specimen acquisition and processing. This shared leadership ensures maximal utilization of samples without compromising patient care. This centralized, comprehensive Core will contribute significantly to the success of the multidisciplinary and translational research projects outlined in this proposal.

Public health relevance
This Core is essential for collection and distribution of well-annotated biospecimens and fulfills the tissue resource requirement of the SPORE.